Simultaneous PET/MR Imaging of Brain Glucose and Oxygen Metabolism to Assess Energy Deficits Related to Alzheimer's Disease and the Response to Intervention

PROJECT SUMMARY
There are now close to six million people in the Unites States living with Alzheimer’s disease and related de-
mentias (ADRD) and this number is only expected to grow as the population continues to age. The current lack
of effective treatments for ADRD speaks to the need to better understand the multiple pathophysiological factors
that contribute to these complex diseases. There is growing evidence that age-related metabolic dysfunction
plays a role in the Alzheimer’s etiology. The link between vascular risk factors and AD is explained in part by
insufficient nutrient delivery to match the high energy demands of the brain and less efficient energy production
as the brain ages. The concept of a “brain energy gap” has led to treatments aimed at enhancing energy pro-
duction and cognitive performance, notably, ketogenic dietary supplements. These have been shown to increase
cerebral ketone metabolism in AD patients, suggesting improved aerobic metabolism. However, this hypothesis
has not been tested given the complexity of imaging oxygen and glucose metabolism. Positron emission tomog-
raphy (PET) is the current standard, but the procedure requires 18F-fluorodeoxglucose (FDG) to measure glucose
metabolism, 3 15O-tracers to measure oxygen metabolism and blood flow, and arterial sampling for quantification.
We hypothesize that cerebral oxygen and glucose metabolism can be imaged noninvasively within a
single session using hybrid PET/magnetic resonance imaging (PET/MRI). Our team has developed a robust
quantitative blood oxygenation level dependent contrast (qBOLD) method of imaging oxygen extraction, which
can be combined with MRI-based perfusion (arterial spin labeling, ASL) to map cerebral oxygen metabolism. In
tandem, we have developed a PET approach for quantifying glucose metabolism that does not require arterial
catheterization. Combining these methods on a PET/MR scanner provides the ability to image oxygen and glu-
cose metabolism simultaneously and non-invasively, thereby reducing scan time, radiation dose and patient
discomfort. As part of the proposed research, we will validate our qBOLD/ASL method for imaging oxygen me-
tabolism by comparison to 15O-PET. Conducting these studies on a PET/MR system will ensure the PET and
MRI measurements are collected under the same physiological state. The MRI oximetry method will be combined
with FDG PET to investigate the effects of a ketogenic supplement on oxygen and glucose metabolism in AD
patients. The outcomes of this project will include validating an MRI-based method for imaging oxygen metabo-
lism and demonstrating how it can be combined with FDG PET to evaluate a treatment that targets the brain
energy gap associated with AD. Replacing 15O-PET by MRI oximetry would greatly enhance the feasibility of
imaging substrate (i.e. glucose) and total energy metabolism (i.e. oxygen) considering how few PET sites with
15O capabilities remain, while FDG is the most used tracer. The longer-term goals are to provide non-invasive,
neuro-imaging tools for studying individuals with ADRD and evaluate effectiveness of emerging drugs.

Public health relevance
NARRATIVE It is projected that by 2030, one in every five Americans will be of retirement age, and this demographic shift is expected to result in more people suffering from dementia. A key feature of the brain is its need for a constant supply of glucose and oxygen to meet the high energy costs of mental activity. This program aims to develop clinically practical, noninvasive imaging methods based on combined positron emission tomography and mag- netic resonance imaging to assess brain energy in order to better understand how this critical component of brain health is impacted by aging.